Synthetic Biology for Splice Modulating Polyketides

Project Summary. Natural product-derived RNA splice modulators are being developed for the treatment of
acute myeloid leukemia as well as other cancers. As natural products with complex molecular architectures,
analogue synthesis, evaluation, and production scale up have proven challenging. Here we utilize the tools of
synthetic biology as a platform to synthesize complex polyketide splice modulators. The most established set of
splice modulators share a common mode of action targeting the SF3B multi-protein component within the U2-
snRNP of the spliceosome. They also share a common motif comprised of two functional moieties united through
a central diene. Combining the molecular diversity provided by medicinal chemistry with the flexibility and the
ability to scale metabolite production using synthetic biology, we will produce 17S-FD-895, a highly potent, in
vivo active lead for AML. This will overcome the chemical production bottleneck that is preventing this life saving
compound from reaching clinical trials. From this medicinal synthetic biology approach, we will identify a
promising production candidate that has the pre-clinical credentials to be further developed as a novel anticancer
therapeutic.

Public health relevance
Project Narrative. Discovery of natural product modulators of RNA splicing has provided an opportunity for a chemical biology-based interrogation of the RNA splicing processes and for new therapeutic approaches to cancer. Here we provide a path to production of complex polyketides that modulate the spliceosome for anticancer drug discovery and development through a program that combines the strengths of medicinal chemistry with synthetic biological engineering and production.